Linking mania/hypomania with abnormal reward expectancy- and approach-related neural network activity and dopamine release

ABSTRACT. Mania/hypomania, the defining symptom of Bipolar Disorder (BD), is extremely disabling, leading
to significantly impaired health and psychosocial function. Yet, current treatments often have severe side effects;
and relapse rates are high. Pathophysiologically-based treatments, guided by an understanding of the
neurobiological mechanisms predisposing to mania/hypomania in BD, are urgently needed to treat and reduce
recurrence of this defining BD symptom. We seek to elucidate the neurobiological mechanisms underlying two
key characteristics that predispose to, and are associated with, mania/hypomania: elevated reward sensitivity/
goal overvaluation and higher than normal levels of often risky, approach-oriented decision-making and behavior,
which can be triggered in uncertain reward expectancy (RE) and approach-avoidance decision-making contexts.
Based on our prior work, we hypothesize that these characteristics result from: abnormally elevated activity and
connectivity in the ventrolateral prefrontal cortex (vlPFC)-reward network (RNet) but abnormally low or no change
in activity and connectivity in the central executive network (CEN), and lower CEN-RNet connectivity, especially
in the latter decision-making context, for which the etiology is elevated dopamine (DA) release in the RNet. Our
goal is to rigorously assess RNet and CEN DA release in 40 unmedicated euthymic BD adults experiencing
subsyndromal mania/hypomania, and 40 healthy control adults (HC), using positron emission tomography (PET)
during oral amphetamine (AMPH) challenge. By examining relationships among RNet and CEN fMRI activity,
functional and effective connectivity (FC, EC), DA release, and subsyndromal mania/hypomania and AMPH-
induced increases in mania/hypomania, we will advance understanding of the neurobiological mechanisms
underlying mania/hypomania predisposition in BD. We will use [11C]raclopride PET and AMPH challenge to
measure striatal DA release; [11C]FLB457 PET and AMPH challenge to measure cortical DA release; and
midbrain (substantia nigra pars compacta/ventral tegmental area, SNc/VTA) neuromelanin contrast-to-noise
ratio (NM CNR) as a measure of cumulative DA synthesis, to examine relationships between this measure and
AMPH-induced DA release. We aim to: 1. Compare groups on: left vlPFC-RNet activity, FC and EC during
uncertain RE and approach-avoidance decision-making; right dlPFC-CEN activity, FC and EC, and CEN-RNet
FC, EC, during the latter context; and indices of approach-avoidance decision-making; 2. Compare groups on,
and examine relationships among: RNet and CEN striatal and prefrontal cortical PET-measured DA release, and
SNc/VTA NM CNR; 3. Examine associations among RNet and CEN DA release, network-respective fMRI
measures, and indices of approach-avoidance decision-making; 4. Examine relationships among AMPH-induced
changes in, and subsyndromal baseline, mania/hypomania and imaging measures; and group differences in
AMPH-induced changes in mania/hypomania. Our work will elucidate neural network DA release abnormalities
predisposing to mania/hypomania, to help develop targeted therapeutics with fewer side effects.

Public health relevance
Project narrative. Bipolar Disorder, defined by a history of mania/ hypomania (periods of elevated mood and energy), and characterized by heightened sensitivity to rewards and higher than normal levels of often risky, approach-oriented decision-making and behavior, is common, with harmful effects on health, but current treatments often do not work and can have unpleasant or intolerable side effects; therefore, better treatments are needed. Our overarching hypothesis is that mania/hypomania results from abnormally high activity and high levels of dopamine release in the brain reward network (RNet) but abnormally low (or no change in) levels of activity and dopamine release in the brain central executive network (CEN). We will test this hypothesis with multimodal neuroimaging studies measuring activity and dopamine release in the RNet and CEN; and relationships among these measures and indices of approach-oriented behavior, and mania/hypomania, to help develop new treatments that specifically target the RNet and/or the CEN, have fewer side effects, and more effectively reduce mania/hypomania and the likelihood of its recurrence in people with Bipolar Disorder.